Children's National Stimulating Access to Research in Residency (CNStARR) Program (NIAID)

Project Summary/Abstract: In order to address the deficit of pediatrician-­scientists, we seek support from the National Institute of Allergy and Infectious Diseases (NIAID) for the Children’s National Stimulating Access to Research in Residency (CNStARR) Program at Children’s National Health System (Children’s National) in Washington, D.C. This mentored program of research training will expand our existing capacity to recruit and retain outstanding pediatric residents with demonstrated potential and interest in pursuing research careers in three specific content areas of interest to the NIAID: immunology, HIV/AIDS, and airway disease. Each content area was chosen on the basis of the depth and breadth of our locally available and committed investigator/preceptors. The CNStARR program will provide its Scholars with both the didactic competencies and the transformative mentored experiences in basic, clinical, or T0-­T4 translational research to prepare them as successful, independent pediatrician-­scientists. The ultimate goal will be to accelerate the transition of participants to subsequent career development support, particularly the “Stimulating Access to Research and Residency Transition Support,” the planned individual K38 mechanism from the National Institutes of Health (NIH), as well as other mechanisms such as T32 and F32 appointments, our institutional KL2 and K12 awards, or individual K08 and K23 mentored career development awards. We anticipate that CNStARR Scholars will join the future academic leaders in pediatrics and its sub-­specialty areas of relevance to NIAID. Ultimately they will direct research teams, compete successfully for grant support, and add significantly to our understanding of the etiology and treatment of infectious diseases (especially HIV/AIDS) and allergic/immunologic disorders.

Public health relevance
Project Narrative: The Children’s National Stimulating Access to Research in Residency (CNStARR) Program at Children’s National Health System in Washington, DC will be a rigorous mentored program of research training that will expand our existing capacity to recruit and retain outstanding pediatric residents with demonstrated potential and interest in pursuing research careers in three specific content areas of interest to the National Institute of Allergy and Infectious Diseases (NIAID): immunology, HIV/AIDS, and airway disease. CNStARR Scholars will join the future academic leaders in pediatrics and its sub- specialty areas of relevance to NIAID.